Understanding Longitudinal Relationships between Sleep and Menstrual Pain in Adolescents

Project Summary/Abstract
Up to 25% of adolescent females experience severe recurrent menstrual pain, which can have consequential
impact on their school attendance and activity performance. Unfortunately, current treatment strategies are
suboptimal. Despite the high prevalence of menstrual pain, there has been little attention directed toward
developing effective therapies. Sleep deficiency and pain symptoms share a bidirectional relationship; and
sleep deficiency is a risk factor for the development and maintenance of pain. During pubertal maturation,
there are concurrent biological and psychosocial changes that can lead to sleep deficiency, including short
sleep duration and insomnia symptoms, that are heightened by the discrepancy between adolescents’ internal
circadian rhythm and social clock. In particular, post-pubertal females have been shown to develop higher
rates of sleep deficiency compared to males. Moreover, depressive symptoms are also exacerbated by sleep
impairments, that follows a precipitous rise during puberty. Therefore, the objective of this proposal is to
understand the causal relationships between sleep deficiency and menstrual pain during pubertal maturation,
and the daily and longitudinal impact on activity limitations. Using a comprehensive multi-method assessment
protocol to measure sleep patterns in 13-16 year old adolescent females across the different phases of the
menstrual cycle, our aims are to (1) compare sleep patterns and psychological mechanisms across the
different phases of the menstrual cycle, (2) determine the mediating role of psychological factors in the daily
associations between sleep deficiency with pain and functioning, and (3) identify the longitudinal relationships
between sleep deficiency, pain, and daytime functioning over 12 months. This study utilizes a longitudinal
cohort-sequential design to maximize data collection. We will enroll 200 female adolescents of 4 age cohorts
(13, 14, 15, and 16 years) recruited from the community. All study procedures will be conducted remotely. At
each time point (baseline, 4-, 8-, 12-months), adolescents will complete a 30-day ecological momentary
assessment with daily symptom diary and continuous actigraphy monitoring of sleep and activity levels, as well
as survey measures assessing sleep deficiency, pain, and psychological factors. The analytic plan will use
latent curve modeling to evaluate developmental processes by modeling mean trajectories of the outcome
variables across 12-month measurement occasions while dynamic structural equation modeling will be used to
focus on moment-to-moment, within-person dynamics such as variability. This innovative study focuses on a
pivotal time of pubertal maturation for adolescent females, during which there is a convergence of risks for
sleep deficiency, depression and menstrual pain. By elucidating modifiable biopsychosocial factors that may
explain the severity and impact of menstrual pain in adolescents, interventions to treat severe menstrual pain
and reduce its impact on daily functioning can be developed. Findings will inform a future clinical trial to
evaluate a sleep intervention in adolescents with menstrual pain.

Public health relevance
Project Narrative Up to 25% of adolescent females experience severe menstrual pain, which can have consequential impact for their school attendance and activity performance. The proposed research seeks to understand the relationships between sleep deficiency, menstrual pain and activity limitations during pubertal maturation. Sleep deficiency is a modifiable risk factor, and characterization of its etiology will inform future clinical trials to test sleep intervention in adolescents with menstrual pain.